Analyses of neutrophil interaction with immune complexes

ABSTRACT Deposition of antibody-antigen immune complexes (IC) in tissues underlies the pathogenesis of a range of human autoimmune diseases from glomerulonephritis, SLE and arthritis, to transplantation rejection. Infiltrating leukocytes are the cause of inflammatory tissue damage. The primary objective of this competing renewal remains an in depth study of the mechanisms of IC mediated neutrophil recruitment and injury. Receptors for IgG, collectively known as FcγRs, mediate the interaction of antibodies with effector cells. In the current grant period, we provide several lines of evidence that the low affinity activating neutrophil FcγRs in mice, which preferentially complex with IgG-ICs, directly mediate neutrophil accumulation. Neutrophil FcγRs and the leukocyte specific CD18 integrins cooperated to promote IC induced neutrophil slow rolling, adhesion and transmigration, and TNF priming of neutrophils enhanced these processes. There are notable structural differences between neutrophil human and mouse low affinity activating FcγRs. Mice express FcγRIII and FcγRIV which complex with the common γ-chain to signal while human neutrophils express FcγRIIA with the ITAM signaling and ligand binding domain in a single polypeptide chain, and a unique GPI-linked FcγRIIIB. To examine the physiological functions, and the relative roles of the human neutrophil FcγRs in vivo, we expressed human FcγRIIIB and FcγRIIA selectively in neutrophils of mice lacking the common γ-chain (γ-/-) and thus endogenous activating FcγRs. γ-/- mice failed to develop anti-glomerular basement membrane induced progressive glomerulonephritis and soluble IC induced Reverse Passive Arthus reaction as expected. In contrast, mice expressing hFcγRIIA on neutrophils displayed significant tissue injury. Moreover, mice expressing either hFcγRIIIB or hFcγRIIA exhibited significant tissue neutrophil accumulation in both models. Using intravital microscopy, we demonstrate that neutrophil FcγRIIA and FcγRIIIB play specialized context-dependent roles in IC-mediated neutrophil slow rolling, adhesion and transmigration. From these, and related observations, we hypothesize that FcγRIIA and FcγRIIIB serve distinct nonredundant functions in response to ICs, which are differentially regulated. We propose that 1) FcγRIIIB tethering to ICs, supported by CD18 integrins serves a homeostatic role in clearing intravascular ICs, while 2) FcγRIIA mediated recruitment and associated injury is regulated by cytokines, resident mast cells and macrophages, and requires its ITAM motif. In this proposal we will rigorously test these hypothesis using our humanized FcγR transgenics, mouse lines deficient in mast cells or macrophages, and cell reconstitution approaches coupled with well-characterized in vivo models of IC induced inflammation and intravital microscopy. We anticipate that the new information provided by this proposal will increase our understanding of mechanisms of IC-induced neutrophil recruitment and activation and provide therapeutic targets for antibody-mediated inflammation relevant to human disorders.

Public health relevance
The objective of this proposal is to understand the role of human neutrophil FcγRs, receptors for IgG, in autoimmune diseases, which afflict 5-8% of the population. In mice, FcγRs have emerged as critical players in IC induced injury of the lung, skin and joints. However, the relevance of this to human inflammation remains unclear, as there are significant structural differences between activating FcγRs in mice and humans. We have generated mice expressing the two uniquely human activating neutrophil FcγRs, FcγRIIA and FcγRIIIB selectively in neutrophils and shown a predominant role for these human receptors in the initiation of immune complex-mediated diseases. Here we will further determine the physiological role of these receptors in neutrophil recruitment and injury in vivo. We anticipate that this will lead to the identification of therapeutic strategies that target tissue injury in inflammatory and autoimmune disorders relevant to human disease.